Polycystins/TAZ as a novel therapeutic target to treat osteoporosis

Osteoblasts (Obs) differentiate from mesenchymal stem cells (MSCs) and polarize on bone surfaces to produce new bone that fills in cavities created by osteoclast-mediated bone resorption. Polycystins 1 and 2 (Pkd1/Pkd2) and TAZ form a mechanosening complex in mature Obs that plays an important role in the maintenance of bone mass. Genetic loss of Pkd1/TAZ in mature Obs of mice results in osteopenia caused by decreased Ob-mediated bone formation (Ob-BF) and an unexpected increase in bone marrow fat (MAT). This inverse relationship between Ob-BF and marrow adipocytes in compound Pkd1/TAZ deficient mice resembles certain forms of human osteoporosis (OP). Increased MAT in OP is thought to be due to a shift of MSC differentiation to adipocytes at the expense of Obs, and the release of paracrine factors by adipocytes are purported to inhibit Ob- BF. However, increased MAT resulting from disruption of Pkd1/TAZ in mature Ob is not readily explained by effects on lineage commitment. Rather, the direct effects of Pkd1/TAZ in Obs raises the possibility that other mechanisms are responsible for converting Obs to adipocytes. An unexplored possibility is that adipocytes arise from transdifferentiation of Obs. We propose the novel hypothesis that physical forces in the bone microenvironment regulate Ob transdifferentiation to adipocytes (OAT) through activation of Pkd1/Pkd2/TAZ. The R61 phase will: 1) explore the mechanisms whereby Pkd1/Pkd2/TAZ in Obs inversely regulate Ob-BF and MAT in bone, and 2) develop pharmacological tools to modify this process. In Aim 1, mouse genetic approaches will be used to conditionally delete Pkd1 and TAZ in osteoblasts and define the functional interdependence of Pkd1 and TAZ in regulating bone mass. In Aim 2, lineage tracing studies will determine the respective roles OAT or altered lineage commitment in the reciprocal regulation of Ob-BF and MAT in these mice. In Aim 3, we will pursue pre-therapeutic lead design and optimization of novel small molecules that “staple” the C-terminal regions of Pkd1 and Pkd2, and stimulate Pkd1/Pkd2/TAZ to promote osteoblastogenesis and inhibit adipogenesis in Ob cultures. Establishing that Pkd1/Pkd2/TAZ regulates OAT in vivo would be a paradigm shift that challenges prevailing concepts of how bone mass is maintained in health and disease. Optimizing lead analogues that activate this complex would potentially provide a novel treatment for OP. In Aim 4, which will be undertaken in the R33 phase only if the expected outcomes of Aims 1-3 are achieved, we will synthesize sufficient quantities of the lead compounds to characterize in vivo pharmacokinetic (PK) properties and safety profiles, and test the ability of the most promising compounds to prevent bone loss in preclinical mouse models of OP. A role of the mechanosensing complex Pkd1/Pkd2/TAZ to regulate Ob to adipocyte conversion provides a new perspective for understanding the pathological significance of the reciprocal relationship between bone formation and MAT in OP and defines a new therapeutic target for developing drugs to treat OP that uniquely stimulate Ob-mediated bone formation and inhibit MAT through activation of Pkd1/Pkd2/TAZ in mature osteoblasts.

Public health relevance
New anabolic approaches that target primary defects in osteoblast (Ob)-mediated bone formation to increase bone mass are needed to address the current limitations of anti-resorptive agents used to treat osteoporosis (OP). This application explores a paradigm shifting concept that conversion of osteoblasts to adipocytes in OP is a pathogenic mechanism underlying decreased Ob-mediated bone formation and increased bone marrow fat (MAT) observed in OP and proposes that the Pkd1/Pkd2/TAZ mechanosensing complex in mature osteoblasts regulates the conversion of osteoblasts to adipocytes. Proposed studies seek to validate the Pkd1/Pkd2/TAZ complex as a therapeutic target in bone, and to develop a new class of bone anabolic agents that activate this complex to increased bone mass through unique actions to stimulate Ob-mediated bone formation and inhibit bone marrow adipogenesis.